COMBINATION THERAPY OF INTERFERON A2B WITH CHCSF FOR CHRONIC HEPATITIS C

To determine the efficacy of combination therapy with interferon-a-2b and granulocyte macrophage stimulating factor for patients with chronic hepatitis C.